Understanding Ethnic Differences in Cancer: The Multiethnic Cohort Study

This renewal application seeks support for the infrastructure of the Multiethnic Cohort (MEC) Study, which was
established in Hawaii and southern California in 1993-1996 to study risk factors for cancer and other chronic
diseases. The study was designed to take advantage of the ethnic and cultural diversity of the two geographic
areas, as well as the expertise of the investigators in nutrition, ethnic/racial disparities studies, and genetics. It
is the most ethnically diverse cancer cohort in existence. It achieves high cost-efficiency by significantly
supplementing active follow-up information with computerized linkages to SEER cancer registries, vital
statistics, hospital-discharge diagnoses, medical claim data, electronic medical records and geospatial
information. At baseline, the cohort included information on 215,000 men and women, comprised almost
entirely of five ethnic/racial populations: Japanese Americans, Latinos, Whites, African Americans and Native
Hawaiians. The resource was later expanded to include a prospective biorepository of blood specimens from
~70,000 of the participants and urine specimens on a large subset. Leadership of the MEC entails a highly
interactive, team-science approach, and the investigators have amply demonstrated their willingness to share
data/samples, and to participate actively in consortia. Research accomplishments include significant
contributions to understanding both genetic and environmental risk factors for cancer. Over 291 papers
describing our findings have been published during the current grant cycle. In addition, over the last 28 years,
129 NIH grants/supplements have been built around the MEC (77 were active in the current cycle), and more
than 136 students and postdoctoral fellows have been trained on the study. This application describes our
aims over the next 5 years for maintaining and enhancing the infrastructure of the MEC, as well as plans for
methodological research. We project adding 7,253 incident cancer cases in the new 5 years, to the current
48,064 cases; 2,670 of these cases will have pre-diagnostic blood samples, to be added to the current 10,957
cases. We will add 6K FFPE tumor samples to the current ~13K. In addition, this grant renewal will make
possible the continuation of a well-integrated program of research aimed at evaluating lifestyle, environmental,
and genetic risk factors and social determinants of health for cancer and other common chronic diseases,
taking advantage of new approaches, such as dietary quality indices, exposomics, genomics, epigenomics,
microbiomics, metabolomics and multilevel exposures, including spatial environment, structural racism, and
climate change. The MEC will allow the testing of innovative research hypotheses aimed at ensuring that
racial/ethnic health disparities are investigated and that progress in disease prevention applies to all major US
racial/ethnic minorities.

Public health relevance
This renewal application seeks support for the infrastructure maintenance of the Multiethnic Cohort (MEC) Study, established in 1993-1996, to continue a well-integrated program of research testing innovative hypotheses aimed at ensuring that racial/ethnic disparities are investigated and progress in disease prevention applies to major US racial/ethnic minorities. By including 215,251 men and women mostly of 5 racial/ethnic populations (African Americans, Japanese Americans, Latinos, Native Hawaiians and Whites), the MEC is the most racially and ethnically diverse cancer cohort, and its value for etiologic research on chronic diseases is widely recognized. Leadership of the MEC entails a highly interactive, team-science approach; investigators have amply demonstrated willingness to share data and samples.